The biofilm matrix of P. aeruginosa

Project Summary
Biofilm formation has been linked to many chronic bacterial infections. Thus, significant research has been
directed towards understanding the basic biology behind biofilm formation. Biofilms produce an extracellular
matrix that functions, in part, to hold the community together. Pseudomonas aeruginosa represents a
paradigm species for the study of biofilms in the laboratory. The regulation of matrix production and the
carbohydrate component of the matrix have both been examined. However, the protein component of the
biofilm matrix has been relatively understudied. Our groups identified a biofilm matrix protein for P.
aeruginosa, CdrA. CdrA provides structural integrity through extracellular interactions with the matrix
polysaccharide Psl. Outside of matrix proteins that provide structural functions, we predict that matrix
associated proteins can play both nutritional and protective roles for the community. This project will initially
focus on CdrA and its role in the matrix. We will then characterize ecotin a matrix bound protease inhibitor and
three matrix-associated proteases. Finally, we will identify new matrix proteins that associate with eps
component of the biofilm matrix.

Public health relevance
Project Narrative Biofilm formation has been linked to many chronic bacterial infections. Biofilm matrix proteins are an understudied feature of these communities. This project will initially focus on CdrA and its role in the Pseudomonas aeruginosa biofilm matrix and then novel biofilm matrix proteins and investigate their impact biofilm survival and pathogenicity.